Administrative Core

The Administrative Core (Core A) serves as the central hub for management, reporting, and fiscal oversight of
this P01 Program. Core A is designed to facilitate communication, planning, data sharing, and scientific and
fiscal oversight of the component research projects and cores of the Program through specific aims focused on
i) communication and management, ii) scientific review and reporting, and iii) data resource sharing and
regulatory oversight. Core A will oversee all the goals of this research Program, with the long term goal of teimly
and successful execution of the planned program research within budget, according to NIH regulations. The
Core Leader and Program Manager will serve as the primary contacts between project and scientific core
investigators, and will serve as the liaison between research teams. Core A will coordinate, schedule, and
implement monthly and ad hoc internal meetings and teleconferencing among the Program projects and cores;
prepare progress reports and internal compliance filings. Core A will oversee data sharing, data archiving, and
overall record keeping of the program and will insure that the program is fiscally compliant with all NIH
regulations.